Epitope-directed monoclonal antibody production for mosquito immune cells (for malaria)

Luna Labs proposes to develop monoclonal antibodies (mAbs) for use in the identification and characterization of mosquito immune cells for immune responses and validation through various immunoassays and surface plasmon resonance (SRP). Since the project focuses on target proteins expressed in mosquito hemocytes that mediate innate cellular and humoral immunity to pathogens, and the antibodies produced will promote the research on human vector-borne diseases transmitted by mosquitoes.